FACTORS DETERMINING THE COUNTERREGULATORY RESPONSE TO REPEATED HYPOGLYCEMIA

Examine in normal humans the possible determining factors (prevailing insulinemia, depth of hypoglycemia) that may be responsible for the defective counterregulation caused by repeated hypoglycemia.